The biological connection between educational attainment and attention-deficit/hyperactivity disorder in contrasting environments

ABSTRACT
Attention-deficit/hyperactivity disorder (ADHD) is a neurodevelopmental psychiatric condition that
substantially impairs educational and work performance. However, the current studies seeking to evaluate
the clinical and biological relationships between ADHD and educational attainment (EA) were conducted
in European samples from high-income countries. The lack of diversity in these studies halts the possibility
of generalization for different individuals and contexts. Therefore, there is a demand within the science
community to better investigate mental disorders in heterogeneous societies and impacted minorities. In
this sense, countries with high social inequalities, such as Brazil, present a "potential context" for assessing
the impact of social and ethnic disparity-related factors (exposome) on mental health and its relationship
with EA and success at work. The general aim of this proposal is to investigate the biological (polygenic)
links between ADHD, EA, and EA-related outcomes (grade failure, college completion, and functional
illiteracy) in adult individuals from contrasting Brazilian social contexts. To achieve this, we propose a
cross-sectional study that will combine genome-wide and epigenome-wide data in a large sample (n =
5,000) of individuals from two Brazilian regions, São Paulo and Porto Alegre. Cutting-edge bioinformatic
and statistical approaches will be applied to integrate the collected data and a) evaluate if the European
derived polygenic scores for ADHD and EA predict the targeted phenotypes and replicate their biological
relationship in the Brazilian population; b) test if their effects are modulated by contrasting exposomes and
the continuous degree of admixture seen in the Brazilian population; and c) explore if epigenetic markers
play a role in the links between ADHD and EA in this diverse population. This study intends to reveal
potential pathophysiological mechanisms involved in high social impacting phenotypes (ADHD and EA).
The Eurocentric bias observed in genomic, epigenomic, and exposomic studies might be highly detrimental,
as it prevents specific populations of low- or middle-income countries from the benefits of future advances
in genomics. The literature has reinforced the need to study heterogeneous populations, such as Latin
America's, and establish multiethnic biobanks or biorepositories containing individuals from different
environmental backgrounds. Therefore, the present study fits into a highly relevant scientific scenario, and
the raised questions are of worldwide interest.

Public health relevance
PROJECT NARRATIVE Attention-deficit/hyperactivity disorder (ADHD) is a worldwide prevalent neurodevelopmental condition causing impairments in several life contexts. People with ADHD are at increased risk for poor school performance, educational underachievement, and unemployment, which is related to the elevated economic burden of ADHD. The proposed research is relevant to public health because it will help to disentangle the biological mechanisms involved in the interplay between ADHD and educational attainment, and it was designed to decrease the Eurocentric bias seen in genomic and epigenomic studies in mental health.